DP21-001 Pregnancy Risk Assessment Monitoring System (PRAMS)

Specific Aims
New Mexico Pregnancy Risk Assessment Monitoring System, Category A. Core surveillance
Introduction
♦ New Mexico has participated in the CDC Pregnancy Risk Assessment Monitoring System (PRAMS) project since
1997. This long-term data collection and dissemination effort has allowed for timely assessment of maternal and
child health status and health behaviors, as well as monitoring of trends unavailable anywhere else.
♦ New Mexico is a rural state with substantial Health Professional Shortage Areas (HPSA), NM has historical
challenges related to teen births, poverty, high school graduation rates, and access to/use of recommended
preconception and prenatal health care.
♦ NM PRAMS is used to describe the health status and needs of the population served by the Medicaid Managed
Care Organizations (MCOs) (over 63% of NM deliveries are paid by Medicaid), the NM WIC Program, the Navajo
WIC program and the statewide Families FIRST Perinatal Case Management Program. NM PRAMS works closely
with the federal Healthy Start sites in Dona Ana County and Luna County to address a broad range of indicators
related to the reduction of infant mortality, maternal morbidity and increased social support for pregnant and
postpartum women. PRAMS is a crucial surveillance system for monitoring maternal and infant health in NM.
Specific Aims, 2021-2026
Objective 1. Improve the health of New Mexico mothers, infants and families by producing data and
information for use in policy making, program decisions, and public and provider education
Objective 2. Promote and maintain a 65% response rate among all strata and ethnic subpopulations of
NM PRAMS
Objective 3. Assure Effective Program Management including maintenance of partnerships to sustain
NM PRAMS surveillance as an institutional activity
Objective 4. Increase capacity for data analysis and data sharing within the state Tribal Epidemiology
Centers, universities and professional health organizations
Objective 5. Improve PRAMS responsiveness to birth equity and reproductive justice
Innovation or unique approach
NM provides a unique environment requiring innovative approaches to increase survey response rates. Several
initiatives for this application are innovative: a. web-based survey module b. oversample to assure
representation of women of color, especially Black and Indigenous women in New Mexico.

Public health relevance
Office of the Vice President for Research INSTITUTIONAL REVIEW BOARD (IRB) Dr. Merranda Romero Marin, Chair MSC 3 RES New Mexico State University P.O. Box 3001 Las Cruces, NM 88003-8001 Phone: 575-646-7177 Fax: 575-646-2480 Email: [email] DATE: July 11, 2020 FROM: The Office of Research Integrity and Compliance TO: Eirian Coronado Research Assistant: Carol Hust Research Assistant: Glenda Hubbard Research Assistant: Dorin Sisneros Research Assistant: Rosie Lucero Research Assistant: May Montoya Co PI:Del Yazzie Department Head:Michael Landen SUBJECT: Decision Memo for Application #18661 Project Title: Application Type: Review Type: Approval Period: Parent Application: Review Category: New Mexico Pregnancy Risk Assessment Monitoring System Status Report Expedited July 10th, 2020- July 9th, 2021 7 The NMSU Institutional Review Board Chair, Dr. Merranda Romero Marin, has reviewed and approved the above application for the conduct of research involving human subjects. The application was reviewed in accordance with the review process outlined in 45 CFR 46.110(b)(2) - Category 7 (Status Report 1). The research must be conducted according to the proposal/protocol that was approved by the IRB. Any changes in the research, instruments, or the consent document(s) must be submitted to the IRB prior to implementation. Additionally, any unexpected hazards or adverse events involving risk to the subjects or others must be reported immediately to the IRB, using the appropriate form, within the time frame specified in the NMSU Principles and Procedures for the Conduct of Research Involving Human Subjects. Note: Data collected during a period of lapsed approval is unapproved research and can never be reported or published as research data. Please note that the IRB approval is valid for one (1) year. Pursuant to NMSU institutional policy, the IRB must review and approve all research protocols involving human subjects at intervals appropriate to the degree of risk, but no less than once per year. Therefore, in order to continue your project after the above approved period you must submit an annual Status Report prior to the above referenced approval period. .